Contribution of Myeloid-Derived Suppressor Cells to Neuro-Inflammatory Alterations and Disease Progression in Glioblastoma

ABSTRACT: Glioblastoma (GBM), the most common primary brain tumor, remains uniformly lethal due to many
factors, including a potently immune-suppressive microenvironment. While attempts to alter immune activation
have been successful in other advanced cancers, a series of diverse strategies has yet to markedly increase
GBM patient survival. These results demonstrate a key clinical barrier to success and underscore the need to
better understand the immune-suppressive GBM microenvironment, which is part of a unique neuroimmune
system. Central to immune suppression in GBM is the presence of myeloid-derived suppressor cells (MDSCs),
an immature lineage comprised of monocytic (m) and granulocytic (g) subsets that potently suppresses cytotoxic
immune response. Interrogating the function of MDSCs in GBM has been a major focus of our laboratory. Using
an integrated approach, we have shown that MDSCs associate with poor GBM prognosis, drive cancer stem cell
function, and interact with the tumor through multiple signaling networks that can be neutralized to increase
immune activation. We have also interrogated MDSC subsets to reveal differences in localization and function
in a sex-specific manner and identified MDSC subset signaling programs that can be altered to increase immune
activation and decrease GBM growth. While our work has implicated MDSCs as biomarkers and drivers of GBM
progression and identified them as next-generation therapeutic targets, there are several knowledge gaps that
remain, and addressing them is the focus of this application: it remains unclear how MDSCs originate and the
extent of their plasticity; it is unclear how MDSC lineage commitment is informed by cell-intrinsic programs and
is altered as a result of interaction with unique neural microenvironments, microbial interactions, and signaling
programs; and the efficacy of targeting MDSC subsets in combination with immune activating strategies has yet
to be determined. The overarching hypothesis of this application is that MDSC subset lineage commitment is
driven though the integration of cell-intrinsic (including sex-specific genetic and epigenetic programs) and cell-
extrinsic (including systemic factors from the gut-brain axis) interactions that can be leveraged for the
development of more effective anti-GBM therapies. Through this R35 mechanism that allows for longer-
term/flexible funding to develop parallel areas with synergistic potential, we will test distinct aspects of this
hypothesis though three complementary but integrated focus areas: (1) the cellular and molecular basis for
MDSC lineage commitment and plasticity, (2) the response of MDSCs to microenvironmental cues, and (3) pre-
clinical MDSC targeting in combination with immune activating therapies. These studies have immediate
implications for GBM and other neurological disorders and establish a platform for understanding immune
responses in other neurological disorders by providing unique insights into neural/immune interactions mediated
via MDSCs, as well as by assessing brain-penetrant immune-altering therapeutic strategies.

Public health relevance
PROJECT NARRATIVE The nervous system possesses unique immune response aspects that are altered in the context of neurological disorders, ranging from glioblastoma, the most common primary malignant brain tumor, to neuroinflammatory conditions and neurodegenerative disorders. Glioblastoma is highly infiltrated by myeloid-derived suppressor cells (MDSCs) that drive tumor growth and reduce the efficacy of standard therapies, including checkpoint inhibitors. The objectives of this project are to use glioblastoma as a model for neurological disorders to identify the cellular and molecular basis for MDSC lineage commitment and plasticity, interrogate the response of MDSCs to microenvironmental cues, and evaluate pre-clinical MDSC targeting in combination with immune activating therapies.